Chemical Specific Measurements of Cellular Heterogeneity in Organoids

Project Summary
The central theme of this proposal is to develop technologies that will enable the extraction of chemical infor-
mation from organoids. Organoids are cell cultures that are grown directly from human or animal tissues and
can be generated from either healthy or diseased specimens. They are disease-agnostic and have been gen-
erated from almost every organ in the human body, making them a valuable resource to study fundamental bi-
ology, structure, and reactivity. Because they can be grown directly from human patients, there is considerable
buzz surrounding them for their applications in disease prognosis and evaluating transplantation success. They
also hold great promise in the arena of drug development, especially given new changes in legislation. In late
2022, the legislation governing drug testing in the United States was altered with the FDA Modernization Act
2.0. Previously, all new therapeutics had to be tested with an animal model prior to reaching the American pub-
lic. However, with these laws in place, the use of organoids to evaluate new drugs is not just allowed but en-
couraged. Despite these advances, the analytical strategies used to analyze organoids are lacking, especially
protein analysis. In most organoid studies to date, protein analysis is completed by immunohistochemistry or
cytokine arrays. While these methods offer information on a specific, pre-selected short list of proteins, they do
not allow any novel protein discoveries. Especially in the arena of drug testing, where evaluation of off-target
effects is critical, a discovery-based method that allows broad sampling of the proteome is needed. In this pro-
posal, we outline the development of a suite of mass spectrometry approaches that will enable exploration of
the organoid proteome, in a cell specific manner. Using magnetic sorting to separate the different cellular spe-
cies of interest, followed by global mass spectrometry profiling, we will parse the relative contributions to the
proteome for the different constituent cell types that encompass the multicellular organoid. The proteomic
changes will then be validated by means of imaging mass spectrometry analysis on the organoid sections. The
research to be conducted will be with lung organoids, based on a current successful collaboration between our
laboratory and a group of pulmonologists, however the methods we develop will be applicable to organoids
grown from any organ in the human body, thus impacting a wide range of human diseases. As we develop our
methods, we will explore proteins involved in senescence, a fundamental cellular process characterized by a
gradual deterioration of the functional characteristics in a mammalian cell. Senescence occurs throughout the
human body yet the protein markers commonly used to characterize it lack specificity. With the combination of
relevant lung organoid models and global discovery proteomics, we will elucidate alternative and better mark-
ers for senescence in the human lung. Again, while our methods will be developed with lung cells, these ap-
proaches will be applicable to organoids grown from any organ. With these advances, organoids will be poised
to expand on their clinical promise in the areas of disease prognosis, transplantation, and drug screening.

Public health relevance
Project Narrative Organoids are multicellular culture models that can be grown directly from human tissue and have enormous promise for prognosis, transplantation, and personalized drug testing. However, there is currently no good method to analyze the protein composition in an organoid with cellular specificity. In this proposal, we outline the development of a suite of mass spectrometry centered methods that will enable robust proteomic analysis of the distinct cellular populations in organoids.